Ending HIV/AIDS among People Who Use Drugs: Overcoming Challenges

Abstract – Pilot Projects and Mentoring Core
The Pilot Projects and Mentoring (PP&M) Core provides pilot project funding for
investigators undertaking innovative research to make progress toward Ending
HIV/AIDS among PWUD. The Core solicits pilot project proposals from early career
investigators and from more senior investigators who are new to conducting research
related to Ending HIV/AIDS. The Core works to increase the diversity of investigators by
encouraging those from underrepresented groups to apply for pilot funding. In addition,
the Core provides an empirically-informed mentoring program that includes several
components: a cross-disciplinary mentoring team; a two-tiered approach with primary
and ancillary mentoring supports; structured support for mentors; and individual
development plans. The Specific Aims for the Core are: (1) Solicit, review and evaluate
pilot projects; (2) Ensure mentoring and training of new investigators; and (3) Facilitate
the professional success and independence of new and other investigators participating
in the Core activities. The CDUHR Leadership Group will participate in developing Pilot
Project RFAs and mentoring will be provided by senior CDUHR-affiliated investigators.